Data Science Shared Resource

The development of modern high-throughput biotechnologies and the rapid generation of high-complexity
biological data has revolutionized the way cancer is studied. Over the last six years, novel artificial intelligence
(AI) algorithm developments together with ever-growing big data generation provide unprecedented
opportunities for cancer research, but also major challenges for handling, analyzing, sharing, integrating, and
interpreting big data. Recognizing the importance of these data, the Data Science Shared Resource (DSSR) of
Simmons Comprehensive Cancer Center (SCCC) was established in 2010 under the leadership of Yang Xie,
PhD. The goal of the DSSR is to provide comprehensive informatics, data analytics, data integration, and data
management support for SCCC investigators. Specifically, the DSSR provides (1) access to high-performance
computing systems, (2) support for bioinformatics and data analyses, including high-throughput molecular data
pre-processing, quality assessment and analysis, and cancer image data analysis, (3) support for data
integration and risk prediction modeling, including integrative analysis, biomarker discovery, and development
of prediction models for clinical outcomes, (4) support for data management and data-sharing, including
developing comprehensive databases and facilitating investigators’ use of publicly available datasets and
bioinformatics tools, (5) data science support for grant applications, and 6) analytical tools/software distribution
and education. In addition, the DSSR has developed a series of cancer data commons and web portals for lung,
kidney, and liver cancers, which are high-priority research areas in the SCCC catchment area. The DSSR also
developed computational tools to curate and integrate data from electronic health records (EHR) with data from
SCCC-driven genomic, imaging, and tissue analysis research. The DSSR will continue to develop, maintain, and
apply these integrated platforms to support SCCC projects. In the current project period, DSSR services were
utilized by 136 investigators across all five SCCC research programs and provided key contributions to support
the success of more than 15 NCI-funded research project grants and over 200 peer-reviewed publications,
including work published in high-impact journals such as Nature, Science, Cell, JAMA Oncology, Cancer
Discovery, Lancet Oncology, and Nature Genetics. DSSR services are made possible by the accumulated
experience of the staff and by innovative, unique, and customized approaches to solving data analysis
challenges. With strong support from SCCC and highly cost-effective operations, the DSSR provides extensive
services for many SCCC members and has provided critical contributions to the scientific needs and objectives
of SCCC.